1/2 The University of Massachusetts, Boston - Dana-Farber/Harvard Cancer Center U54 Comprehensive Partnership for Cancer Disparities Research

The goal of the parent University of Massachusetts Boston (UMass Boston) and Dana-Farber/Harvard
Cancer Center (DF/HCC) U54 CA156734 Partnership is to “pursue Partnership activities and research that
will bridge the divides in cancer disparities science, research education, and outreach through innovative
research, training, and practice.” This NOSI will extend these activities into the data science space by
coupling the need to embrace new paradigms for computational research to equally urgent requirements
to diversify and grow the computational genomics data sciences (CGDS) research workforce. This will be
pursued through the accomplishment of 3 Specific Aims designed as a three-part educational and
community development program: 1) Build a CGDS immersion workshop for undergraduate students of
diverse backgrounds; 2) Develop complementary courses in CGDS, and 3) Aim 3: Build a data science
community through mentored research and an inclusive “data club.” The scientific goal of this project is to
resource the development and implementation of interdisciplinary education and training in biological data
sciences that will enable the translation of data into biological insights to address cancer and cancer
disparities. The community goal of this project is to offer many opportunities for training, education, and
community building, including experiences specifically aimed at expanding participation of
underrepresented minorities in genomics-focused biology and data science. The accomplishment of these
goals will build a sustainable program to train diverse students as “multilingual” scientists with a broad
range of skills and knowledge in both data and biological sciences that can effectively communicate and
exchange ideas across disciplines to advance cancer- and cancer disparities-focused genomic sciences
research.

Public health relevance
Translating data into biological insights remains a critical challenge, and there is a growing need to train “multilingual” scientists with a broad range of skills and knowledge in both data and biological sciences, and the ability to effectively communicate and exchange ideas across disciplines. The goal of this project is to invest in both human and institutional capacity for computational genomics data sciences (CGDS) at University of Massachusetts Boston through a three-part educational and community development program. This approach couples the need to embrace new paradigms for computational research to equally urgent requirements to diversify and grow the CGDS research workforce.